Implementing a church-based parenting intervention to promote NIDA prevention science among Hispanics

PROJECT SUMMARY
Hispanic populations in the United States (US) continue to be seriously impacted by persistent health
disparities. According to the 2017 Monitoring the Future Study, Hispanic adolescents had the highest rates of
use of most illicit drugs compared to other ethnic groups. When considering differential risks among Hispanics,
US-born youth in low-income first-generation immigrant families are at high risk for experiencing poverty,
discrimination, and barriers to access services. These adolescents can also be exposed to deleterious parent-
youth cultural conflicts, which may increase their risk for behavioral problems, including the use of alcohol and
other drugs. Contextual stressors also have a negative impact on the quality of parenting practices of
immigrant parents, with associated deleterious consequences for their adolescent children. Although parent
training (PT) interventions constitute the gold standard for strengthening parenting practices that are effective
protective factors in the lives of adolescents, the availability of efficacious culturally adapted PT interventions in
underserved Hispanic communities remains scarce throughout the US. Thus, there is an urgent need in the
implementation science (IS) field to identify implementation strategies aimed at addressing service gaps
affecting Hispanic populations. A promising alternative consists of relying on third sector organizations, such as
faith-based organizations, to integrate prevention programs in underserved communities. The current R34
investigation will consist of the implementation and modest refinements of a culturally adapted version of the
evidence-based PT intervention known as GenerationPMTO.© Our rationale is that implementing efficacious
prevention interventions in faith-based organizations constitutes a key alternative to address service barriers
experienced by underserved populations. We also propose that by training lay members of target communities
as prevention interventionists, the sustainment of prevention programs can be significantly enhanced. This
study has relevance as we focus on a population that remains understudied in the IS field. Our research team
is composed of the largest faith-based organization serving Hispanics in Travis County, Texas, as well as a
core research team affiliated with the University of Texas at Austin, expert IS consultants, and community-
based organizations serving Hispanic populations. The research aims of this R34 investigation are: (a) To
implement a pilot study aimed at refining the CAPAS-Youth curriculum and study procedures, (b) to implement
a randomized controlled trial, aimed at empirically testing the efficacy of the CAPAS-Youth intervention with
first-generation low-income Hispanic families in Travis County, (c) to measure barriers and facilitators
associated with the implementation of the CAPAS-Youth prevention intervention in the target context, and (d)
to measure relevant implementation outcomes to inform a future R01 effectiveness trial. The investigation has
high

Public health relevance
PROJECT NARRATIVE Hispanic young adolescents are at a disproportionate high risk for cigarette use, alcohol use, and use of the majority of illicit substances. Furthermore, low-income Hispanic families experience significant barriers to engage in efficacious culturally adapted prevention interventions. By proposing an investigation aimed at testing a prevention implementation approach with undeserved Hispanic families, the proposed R34 study is directly responsive to NIH and NIDA strategic goals focused on reducing health disparities and increasing the public health impact of NIDA research.